Development of a Viral Vector Sizing Tool to Improve Gene Therapy Analytics and Reduce the Cost of Drug Development

ABSTRACT
NanoEngineering is commercializing nanoparticle characterization technology for gene therapy vector analytics.
Licensed from Yale, our proprietary electrospray differential mobility analysis (ES-DMA) method quickly and
easily measures the size of virus capsids at angstrom-scale resolution. This SBIR proposal builds on our
preliminary success toward developing our portable benchtop instrument, NanoRanger, as a standard tool to
monitor and improve the purity of viral vectors and reduce production costs. Adeno-Associated Virus (AAV) is
the most commonly used viral vector for in vivo gene therapy but commercial production methods are currently
unable to achieve complete separation of “full” AAV capsids from contaminating “empty”, and “partial” / “over-
filled” particles. These species are therefore often present in clinical preparations, reducing efficacy, increasing
production costs, and posing serious health risks for patients. For effective analysis by ES-DMA it was necessary
that upon electrospray ionization, AAV vectors would exhibit measurable differences in size based on their DNA
cargo. Research carried out with our partners at MegaDalton Solutions and Vector Biolabs on 11 cargo-
containing AAV9 samples and certified empty reference materials has now shown that spectra obtained from full
AAVs are readily distinguishable from the empty capsid profile and display shifts in particle diameter strongly
correlated with the genomic length of packaged DNA cargo. Direct comparison of full / empty capsid ratios was
assessed against parallel testing by charge detection mass spectrometry (CD-MS), a known gold-standard.
Strikingly, these results closely matched those obtained by ES-DMA for 8 of 11 samples. Successful commercial
development of this technology will help the industry meet cost reduction goals by shortening feedback about
process improvements in downstream purification. Long term, NanoRanger will target upstream production
monitoring where metrology tools are needed most. The specific aims of this project are first to establish a
reproducible protocol for AAV analysis across various serotypes and genomic cargos, and second to confirm
robust mass/size correlation through continued parallel CD-MS testing, targeting a 95% Confidence Interval for
mass/size correlation and submission for peer-reviewed publication. Third, we will deploy a NanoRanger
prototype to Vector Biolabs for on-site beta testing at their AAV production facility in Malvern, PA. We expect
Phase 1 to establish ES-DMA as a novel QC method for AAV analytics and to confirm the unique advantages of
our approach for bio-nanoparticle characterization, ultimately helping to improve safety and reduce costs of
lifesaving therapeutics for millions of patients worldwide. We anticipate a total annual sales opportunity of $50M
based on a target market of over 500 analytical labs and 1000’s of bioreactors. Phase 2 will further develop and
market NanoRanger as a new gold standard for AAV analytics. We will also continue process development for
other applications in AAV research and shelf-life stability QC, develop autonomous operation for real-time
production monitoring, and expand our focus to other viral and non-viral gene therapy vectors.

Public health relevance
PROJECT NARRATIVE NanoEngineering is commercializing a benchtop analytical instrument, NanoRangerä, that is capable of measuring the size of nanoparticles from 5-100nm with angstrom-scale resolution. We have developed a technique to expand this technology to adeno-associated virus (AAV) commonly used in gene therapy. By providing a rapid low-cost method for detecting dangerous impurities prevalent in clinical AAV preparations, this tool will help meet an urgent need for more effective viral vector analytics to improve patient safety and reduce the costs of gene therapy.